"Dysregulated Polyamine Metabolism in H. pylori-associated Gastric Inflammation and Disease Progression"

Stomach diseases are very frequent in Veterans. Helicobacter pylori is the most common bacterial pathogen in
humans, and stomach infection is common in VA patients, especially due to deployment related acquisition. H.
pylori causes chronic gastritis, peptic ulcer disease, and in 1-3% of patients, progression to gastric cancer, the
fourth leading cause of cancer deaths worldwide. In this Merit Review program, we have focused on the role of
polyamines in gastric disease. We reported during the current award that 1) gastric epithelial cell (GEC)-specific
deletion of ornithine decarboxylase, the rate-limiting enzyme for polyamine synthesis, protects mice from H.
pylori-induced gastric inflammation, GEC proliferation, and immune dysregulation; and 2) total deletion of
spermine oxidase (SMOX), which back-converts the polyamine spermine (Spm) to spermidine, prevents gastric
inflammation and carcinogenesis, immune dysfunction, and blocks DNA damage and carcinogenic signaling.
We now show that GECs exposed to H. pylori produce acrolein, a highly damaging reactive aldehyde, and that
this is generated by SMOX. Acrolein can also cause generation of other electrophiles by causing lipid
peroxidation. Data from our current CSRD endoscopic study in VATVHS patients show increased acrolein and
other electrophile adducts in gastric tissues and organoids from VA patients infected with H. pylori. We also
reported that scavengers of electrophiles, including 2-hydroxybenzylamine (2-HOBA), which has been safely
tested in humans, markedly attenuate gastric carcinoma in our models. The transcription factor nuclear factor
erythroid 2-related factor 2 (NRF2), encoded by the gene Nfe2l2, enhances detoxification of reactive aldehydes
and our data show that its activation is increased in VA gastritis tissues and in mice with dysplasia and carcinoma.
Importantly, we have isolated VA patient H. pylori strains that cause a high frequency of gastric carcinoma in our
INS-GAS mouse model. We hypothesize that SMOX-generated electrophiles increase gastric inflammation and
carcinogenesis, and this process is regulated by NRF2, making NRF2 activators and electrophile scavengers
new potential therapeutics. Our Aims are: Aim 1) To determine the cell-specific roles of SMOX-derived
electrophiles; we will use C57BL/6 and INS-GAS mice with specific deletion of Smox in A) GECs and B) myeloid
cells. These mice will be infected with highly pathogenic H. pylori strains from VA patients, and treated ± Spm,
the SMOX substrate. We will study electrophile adducts, inflammation, dysplasia, and carcinoma. Aim 2) To
determine if NRF2 reduces SMOX-derived electrophiles. We will use mice with specific deletion of Nfe2l2 in A)
GECs and B) myeloid cells. These mice will be infected with VA H. pylori, and we will assess electrophile adducts,
inflammation, and markers of advanced lesions, and test if Spm increases disease and if 2-HOBA reduces
disease in Nfe2l2-deficient mice. In 2C, we will use INS-GAS mice infected with VA H. pylori and determine
effects of NRF2 activators, sulforaphane and dimethyl fumarate, on electrophile production, inflammation, and
carcinogenesis. Aim 3) To determine if electrophiles and NRF2 are targets for prevention of carcinogenesis in
Veterans. We will enroll 80 patients at the VATVHS undergoing clinically indicated upper endoscopy, across the
histologic disease spectrum that includes normal, gastritis with and without H. pylori infection, and advanced
lesions of atrophic gastritis and intestinal metaplasia. In A) we will determine if gastric levels of adducts of reactive
aldehydes/electrophiles are inversely correlated with NRF2 activity, and if plasma electrophiles are biomarkers
of gastric disease. In B) we will directly test molecular and cellular effects of electrophile production using VA
patient-derived gastric organoids stimulated with VA H. pylori ± 2-HOBA ± NRF2 agonists. We will assess
electrophile adducts, DNA damage, and inflammatory/carcinogenic signaling. This research will address the
molecular basis for gastric inflammatory carcinogenesis in Veterans. By using H. pylori strains, biopsy tissues,
plasma, and gastric organoids from VA patients, we can translate our novel animal models into actionable new
strategies for gastric disease and cancer risk assessment, chemoprevention, and treatment for Veterans.

Public health relevance
Helicobacter pylori is a type of bacteria that infects the stomach of half of the world’s population. It causes chronic damaging inflammation and can lead to peptic ulcers and progression to precancerous lesions and stomach cancer, the fourth leading cause of cancer deaths. Servicemen/women are frequently exposed to H. pylori when deployed to where this infection is very frequent, and they can acquire highly pathogenic strains that are hard to treat and associated with carcinogenesis in our studies. We have discovered mechanisms that we will now further delineate by which H. pylori causes tissue injury, DNA damage/gene mutations, and carcinogenesis, focusing on stomach tissue samples and H. pylori strains from our VA endoscopy patients. Using novel mouse and human cell model systems, we will establish links between molecules called polyamines and highly injurious reactive aldehydes, and the abnormal responses in immune cells and epithelial cells. We will establish new molecular-based strategies for disease prevention and treatment in Veterans.